Targeting MSUT2 with small molecules to ameliorate pathological tau

Abstract
In frontotemporal lobar degeneration, Alzheimer’s disease (AD) and related tauopathies, tau neuropathology
correlates with severity of dementia. However, interventions for AD and AD related dementias (ADRDs) are
largely limited to treatment of symptoms that do not directly alter tau pathology or the resultant
neurodegeneration, with only one Aβ-directed immunotherapeutic (Aduhelm) recently receiving a controversial
accelerated approval for disease modification. Although investigation into additional Aβ targeted
immunotherapies continues, the obvious need remains for the development of tau-targeted disease-modifying
therapeutics. Our work has demonstrated that MSUT2 controls neuronal susceptibility to tau toxicity in the
mammalian brain. The mechanism of MSUT2 modulation of tauopathy involves the MSUT2 CCCH domain
binding to poly(A) RNA, as deletion of the CCCH domain prevents neurodegeneration in animal models of
tauopathy. High throughput screening of over 100,000 high diversity compounds has identified many active dose-
responsive compounds that inhibit MSUT2 poly(A) RNA binding activity, including several classes of compounds
exhibiting promising structure-activity relationships. The identification of drug-like small molecules that inhibit
MSUT2 binding to poly(A) RNA will provide a pharmacological means of intervening against tauopathy. We
hypothesize that small-molecule inhibitors of MSUT2/poly(A) RNA binding will slow or reverse tau
pathology and the toxic consequences of pathological tau. The specific aims of this proposal are to optimize
potent and specific brain-penetrant MSUT2 inhibitors and use them to demonstrate proof-of-concept therapeutic
approaches to treating tauopathy. Successful completion of these aims will set the stage for future translational
studies by both generating MSUT2 specific tool compounds and further validating a novel therapeutic target for
pharmacological intervention in tauopathy disorders.

Public health relevance
Narrative Statement To date, few clinical trials for AD and related tauopathies have specifically targeted pathological tau, yet neurofibrillary tangles are the diagnostic neuropathological hallmark of AD and other tauopathies most closely associated with cognitive decline. To help fill this gap, we propose to develop a novel neuroprotective strategy that targets pathological tau in AD and related dementias. Specifically, we propose to develop and optimize small molecule inhibitors of MSUT2 binding to poly(A) RNA. These novel tool compounds will be used to provide a proof-of-concept demonstration that inhibiting MSUT2 can slow or reverse pathological tau deposition, and they will support mechanistic investigation of MSUT2 as a critical modulator of pathological tau.